Administrative Core

PROJECT SUMMARY
The overarching goal of the Administrative Core is to oversee and coordinate all scientific, regulatory,
administrative and fiscal responsibilities of the Program Project grant. The Administrative Core will accomplish
its goal through the following specific aims:
1. Ensure integration of all Projects and Cores by managing all oversight strategies, including
coordinating the meetings of the three committees (Executive and the External and Internal Advisory
Committees) and implementing the recommendations of these Committees.
2. Realign resources based upon advice from the External and Internal Advisory Committees
in collaboration with the Executive Committee (Program Leaders and Project/Core
Leaders).
3. Administer and implement the multiple Principal Investigator Plan.
4. Organize the monthly meetings of the Executive Committee, annual meetings of Internal
Advisory Committee, and annual meetings of External Advisory Committee.
5. Organize the P01 yearly retreat to assess overall P01 progress, based upon quantitative
milestones, and plan and implement next steps making use of the reports from the Internal and
External Advisory Committees.
6. Provide governance and accountability for the CAV trial
7. Provide fiscal accountability via coordination with institutional and NCI staff.
8. Document productivity of all Projects and Cores, as defined by discrete endpoints such as
manuscripts, filed provisional patent applications, and invited lectures.
9. Prepare all progress reports and responses to External and Internal Advisory Committees.
10. Coordinate and oversee all scientific, regulatory, administrative, and fiscal interactions between the
University of Virginia, Eastern Carolina University, Memorial Sloan Kettering Cancer Center,
University of New Hampshire, and Penn State University.
11. Ensure accountability and governance of all biostatistics, bioinformatics, and “-omic”
methodology across all projects and cores.
12. Coordinate Data Sharing modalities between Institutions, NIH, Nanotechnology Characterization
Laboratory (NCL), and the public.
13. Coordinate the monthly Core presentations to the Executive Committee that will include descriptions
of the active and pending requests for support from each Project.

Public health relevance
PROJECT NARRATIVE Efficient management between performance sites is critical for success of this Program Project that will document dysfunctional sphingolipid metabolism and signaling as therapeutic targets in AML.